Developing a model of biomedical scientists' propensity to withhold materials, da

This work builds directly on prior empirical research conducted by the PI and his collaborators.[135] Our survey conducted for the National Research Council suggested that patents were not major impediments to the flow of either knowledge or materials among research scientists. Rather, the main determinants of withholding behavior appeared to be scientific competition, prior business-related experience (interpreted as signaling respondent interest in commercial goals), and simply the cost and effort of producing and sharing the requested materials. Moreover, what was subject to friction was not so much intellectual property as the materials used in research[unreadable]thus, tangible, as distinct from intellectual property. (But of note, our survey also found one reason patents do not appear to impede research greatly is that researchers do not check for IP rights. This could change if the law were to be aggressively enforced. There are good reasons patent rights are usually not asserted against research uses, but practices are subject to change, a topic addressed in Project 2.) Our prior empirical findings suggested that an economic model could be fruitfully applied to understanding the drivers of the voluntary flows of research inputs[unreadable]data, findings, materials[unreadable]among researchers, and the consequent research efficiencies realizable from such flows.[136] For example, the empirical finding that IP currently has little effect on the flow of knowledge among academic scientists is consistent with the fact that accessing patent-protected knowledge by academics without permission of the owner is rarely costly since it is often disclosed in the scientific literature, and the expected penalties for infringement of another academic's patent are slight, at most, assuming the owner is even aware of the infringement to begin with.[137] (Situations in which data in scientific publications and in patents are not sufficient to circumvent patents, which our model would also have to accommodate, will be a subject of Research Theme 1.) An economic calculus is also consistent with the greater prominence of friction in the exchange of materials because the provision of materials often requires effort and entails costs. Moreover, it is quite simple and inexpensive to withhold materials from the perspective of the scientist who is asked to provide them. Finally, the apparent role of greater scientific competition in increasing the likelihood of withholding is also consistent with an economic calculus applied to the voluntary provision of materials since more intense scientific competition should increase the expected benefit of withholding.